Complications and Restoration of Functional Mobility and Balance Impairment in NADCs (HIV/AIDS/Aging/Cancer)

PROJECT SUMMARY
Non–AIDS-defining cancers (NADC) are increasing rapidly and constitute the majority of cancers
diagnosed in people living with HIV (PLWH). Accelerated aging in HIV and cancer lead to compromised
skeletal muscle, which contribute to poor functional mobility and culminates in frailty and comorbidity. Frailty
and balance impairment are common in patients with cancer and in PLWH. The insult to balance in the setting
of a NADC diagnosis in conjunction with HIV infection, is very likely compounded, leading to greater frailty
outcomes compared to PLWH as well as increased risk for fracture.
Balance deficits impose limitations and can impede safe walking contributing to falls and falls-related
complications. Our pilot data indicate that PLWH have highly impaired standing balance that is associated with
inefficient weight transfer and an inability to regulate balance leading to greater fall risk. This study will use new
quantitative methodologies including state-of-art technologies and engineering models to quantify functional
balance, both the static and dynamic domains beyond established clinical assessment battery. These
biomechanical indices may help predict frailty precursors to better understand how cancer, HIV infection and
aging exacerbate each other, and could potentially inform management of mobility disorders in this patient
population.
Interventions to improve key aspects of balance control are likely to favorably impact safe functional
mobility while performing everyday activities. A primary question at this juncture in our knowledge is whether a
multi-component balance program can improve functional independence in those aging with NADC through
attenuating the disabling consequences of frailty, which will inform future evidence-based multi-component
interventions.
This is an administrative supplement for P30 Cancer Centers Support Grants (CCSG) to stimulate research
in NADCs in Aging Populations under a High Priority topic of research. Our overall objective is to
comprehensively assess and compare balance and mobility in older NADC to older PLWH without NADC of
similar socioeconomic background and to test the feasibility of a resistance and balance training program to
improve balance, strength and physical activity. The proposed research has significant public health impact
and will provide critical pilot data for a larger randomized controlled trial. Improvement of strength and postural
stability is a significant and novel area of investigation in NADC.